Vivli: A Generalist Repository For Clinical Trials Data

Abstract:
The vision of the Generalist Repository Ecosystem Initiative (GREI) is to develop collaborative approaches for data management and sharing through inclusion of established generalist repositories in the NIH data ecosystem and better enable search and discovery of NIH funded data in the generalist repositories. This is one of the steps in the modernization of the data resources ecosystem and aligns with the NIH Strategic Plan for Data Science.
The primary mission of the Generalist Repository Ecosystem Initiative is to establish a common set of cohesive and consistent capabilities, services, metrics, and social infrastructure across various generalist repositories. A secondary mission is to also raise general awareness and facilitate researchers to adopt FAIR principles to better share and reuse data.
The objectives of the project are to work together with the other awardee teams to develop a “co-opetition plan” that include a commitment to a solution architecture, data submission and QA/QC capabilities to support relevant use cases, train and educate users, as well as provide usage analytics and reporting to the NIH.

Public health relevance
No Text